Precision Cardio-Metabolic Phenotyping for Genetic Discovery and Risk Prediction

Type 2 diabetes (T2D) and cardiovascular disease (CVD) are among the leading causes of morbidity and
mortality in US Veterans, as well as the US population at large. T2D is a widely-recognized risk factor for CVD,
and T2D leads to worse CVD outcomes. However, there remains considerable clinical heterogeneity among
individuals with T2D. Even among individuals with apparently similar glycemic control, there is significant
variability with respect to who will develop CVD. To develop more effective strategies to prevent CVD in this
high-risk population, better approaches for quantifying CVD risk are needed. Using novel computational
approaches, we will consider dense phenotype and genotype data to identify the subpopulations of individuals
with T2D who are at the highest risk of heart and vascular disease. In Aim 1, the relationship between traditional
CVD risk factors, such as cholesterol, blood pressure, and smoking, and three heart and vascular disease
phenotypes: peripheral artery disease (PAD), coronary heart disease (CHD), and cerebrovascular disease, will
be tested. To account for the fact that these outcomes frequently occur in the same individuals, statistical models
that treat the traits as correlated-within person outcomes will be used. To determine if the addition of genetic
information improves the prediction of CVD outcomes, the impact of genetic risk scores, based on preliminary
studies from the VA Million Veteran Program and other published work, on the models will be assed. In Aim 2
dense phenotype data will be extracted from the electronic health record and novel artificial intelligence based
biclustering algorithms will be used to identify hidden subtypes of T2D. The association of these subtypes with
CVD outcomes will then be assessed. In Aim 3, a similar approach will be taken to elaborate T2D subtypes
based on DNA variants known to associate with T2D, CVD, and their risk factors. Finally, the genetic and
phenotypic data will be jointly considered. These approaches will be applied across data from both US Veterans,
using the Veterans Aging Cohort Study and the VA population at large (via the Corporate Data Warehouse), and
non-Veterans, using data from the PennMedicine BioBank, Penn Data Store, and UK Biobank. Successful
completion of this project will help to elucidate the phenotype structure of T2D and identify individuals at the
highest risk of T2D. These results will lay the ground work for developing tailored strategizes for CVD prevention
in T2D and help realize the promise of precision medicine for heart and vascular disease.

Public health relevance
Diabetes increases the risk of heart and vascular disease. This can present with blockage of the blood flow to the legs leading to limb loss, blockage of blood flow to the heart leading to heart attack, or blockage of the blood flow to the brain leading to stroke. heart and leg arteries. These conditions are highly interrelated and lead to poor quality of life and premature death. They are among the most common conditions affecting Veterans. This study will help us better identify individuals with diabetes who are at the highest risk of these complications. We will analyzing electronic health records in combination with genetic data in a very large number of Veterans and non-Veterans. This new knowledge will not only facilitate the development of safe and effective novel therapies, but also help us more effectively recommend existing therapies that prevent the onset of disease among Veterans highly predisposed to these conditions.